Respiratory Control in Old Age

By 2030, ~70 million people in the USA will be >65 years old with ~10 million >85 years
old. The studies proposed in this competitive renewal application are motivated by our
previous finding that larger phrenic motor neurons (PhMNs) are selectively lost in old
age and the work of others implicating mitochondrial disruption in motor neuron death.
BDNF/TrkB signaling mediates CREB phosphorylation at serine 133 (pCREBs133), which
promotes mitochondrial remodeling via gene targeting of PGC1a. Activity dependent
pAMPK signaling also mediates pCREBs133 phosphorylation and PGC1a expression. It
appears that BDNF/TrkB signaling in PhMNs is reduced in old age, but activity of smaller
PhMNs persists to support breathing, which may underlie their sparing in old age. It is
also well established that circulating TNFa is elevated with aging. In other cell types, we
found that TNFa selectively activates the IRE1a/sXBP1 ER stress pathway, which
induces mitochondrial fragmentation and mitophagy. Our experimental design involves
a comprehensive array of novel techniques already established and validated in our lab.
The results of the proposed studies will guide development of novel therapeutic
approaches targeting BDNF/TrkB or pCREBs133 phosphorylation (e.g., quercetin) and/or
TNFa induced IRE1a/sXBP1 ER stress (e.g., infliximab) to promote PhMN survival.
Conceptual Framework: We hypothesize that mitochondrial volume density (MVD) and
respiratory capacity (SDHmax) in PhMNs are affected by the balance between
mitochondrial biogenesis and mitophagy. Mitochondrial biogenesis is regulated via
pCREBs133 phosphorylation and PGC1a expression, which is triggered by both activity
(via pAMPK – Aim 1) and BDNF/TrkB.FL signaling (Aim 2). In old age, the influence of
BDNF/TrkB.FL signaling is diminished especially in larger PhMNs, while activity of
smaller PhMNs persists. Furthermore, serum TNFa is elevated in old age, which induces
pIRE1a/sXBP1 ER stress leading to mitophagy (Aim 3).
Aim 1: Determine the role of pAMPK/pCREB/PGC1a signaling in maintaining
mitochondrial volume density in smaller PhMNs..
Aim 2: Determine the impact of reduced BDNF/TrkB/pCREB signaling in age-related
remodeling of mitochondria in PhMNs.
Aim 3: Determine the impact of TNFa induced activation of the IRE1a/sXBP1 ER stress
pathway in age-related remodeling of mitochondria in PhMNs.

Public health relevance
PROJECT NARRATIVE By 2030, ~70 million people in the USA will be >65 years of age and ~10 million will be >85 years old, and with aging of our population, the incidence of sarcopenia (age-related muscle wasting and weakness) will increase, which is a significant predictor of chronic disease and mortality in the elderly. The diaphragm muscle is the most important inspiratory muscle, and it is also susceptible to sarcopenia, which may limit higher force expulsive airway clearance behaviors such as coughing and sneezing and thereby increase the risk for airway infections in the elderly. The proposed studies will examine the mechanisms underlying age-related loss of phrenic motor neurons and diaphragm muscle sarcopenia and explore the development of novel therapies to mitigate sarcopenia.